BIOAVAILABLITY OF ORAL LIQUID AND TABLET FORMS OF DIFLUOROMETHYLORNITHINE

This is a pharmacokinetic study designed to determine if two oral preparations of difluoromethylornithine (DFMO) are biocompatible. We will recruit 10-20 normal volunteers who will receive two single doses of DFMO given one week apart; one dose liquid and one dose tablet. Subjects will be randomly assigned to receive either the liquid or the tablet first. Blood samples will be drawn for pharmacokinetics pre-drug, 30, 60, 90 minutes, 2, 3, 4, 6, 9, 22, and 24 hours following administration. Single-dose pharmacokinetic parameters to be assessed are peak concentration, time to peak, 24 hour AUC and elimination half-life.